Expanding The Genetic Code In Yeast

Nature has allowed the expansion of the genetic code to include two unusual amino acids: selenocysteine (Sec) and pyrrolysine. Interestingly, however, neither of these unique amino acids are utilized by fungi, thus making the yeast Saccharomyces cerevisiae a genetically manipulable blank slate for reconstituting genetic code expansion. This proposal focuses on the hypothesis that reconstitution of Sec incorporation in yeast will dramatically increase our understanding of the mechanism of Sec incorporation as well as allow for the manipulation of this system for the production of site-specifically labeled proteins. The transformation of a UGA stop codon into a Sec codon requires the utilization of a novel translation elongation factor (eEFSec), a selenocysteine insertion sequence (SECIS) element in the 3' untranslated region of selenoprotein mRNAs, and a novel SECIS binding protein termed SBP2. These factors act in concert to alter the coding potential of specific UGA codons by specifying the insertion of the Sec-specific tRNA, Sec-tRNASec. This process is required for the production of 25 human selenoproteins, many of which form an essential line of defense against oxidative stress. In order to rebuild the Sec incorporation system in yeast, we propose to create a series of strains that will allow a stepwise approach to reconstitution. The process will start with Sec- tRNASec, moving up to incorporation of Sec into a luciferase reporter and culminating with a series of genetic screens designed to identify factors that enhance Sec incorporation as well as select for components able to support the site-specific incorporation of unnatural (e.g. fluorescent) amino acids. In addition to the major impact on selenium biology, this project will also provide valuable resources for scientific disciplines that require the analysis of protein structure and function.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project is designed to reconstitute the utilization of selenium in the form of selenocysteine in the yeast Saccharomyces cerevisiae. The unique molecular machinery that is required for selenocysteine utilization will be manipulated to allow protein engineering. In addition, this system will form the test bed for therapeutics agents designed to regulated the production of selenium-containing proteins in vivo. This project is designed to reconstitute the utilization of selenium in the form of selenocysteine in the yeast Saccharomyces cerevisiae. The unique molecular machinery that is required for selenocysteine utilization will be manipulated to allow protein engineering. In addition, this system will form the test bed for therapeutics agents designed to regulated the production of selenium-containing proteins in vivo. __SpecificAimsTextDelimiter__ Specific Aims Since the deciphering of the genetic code, the number of co-translationally incorporated amino acids has risen from 20 to 22, highlighting the flexibility in the fundamental process of translation elongation. The incorporation of selenocysteine (Sec) into proteins at select UGA codons requires a modification of both tRNA biosynthesis as well as protein synthesis. In mammals, at least seven gene products and one cis-acting element are required for the production and incorporation of selenocysteine. The high degree of codon specificity makes this system uniquely poised to provide a means for the incorporation of selenocysteine at any position in any recombinant protein. In addition, modifications of the Sec incorporation system would allow the incorporation of unnatural (i.e. fluorescent) amino acids without the side effect of unwanted stop codon suppression at endogenous termination sites. Interestingly, higher plants and fungi are unique in that they do not utilize Sec and they do not possess any of the selenoprotein synthetic genes, making them a blank slate for the reconstitution and modification of the Sec incorporation pathway. We hypothesize that the genetic code of yeast can be expanded to include Sec by developing an in vivo heterologous system consisting of the complete Sec incorporation apparatus. Thus, here we propose to rebuild the Sec incorporation system in the genetically tractable yeast, Saccharomyces cerevisiae as a means to develop three novel technologies: 1) site specific incorporation of selenocysteine into recombinant proteins, 2) site specific incorporation of unnatural amino acids and 3) improved crystallographic phasing by gold-labeling at defined selenocysteine residues. In the process of developing these technologies, this work will also establish the basal requirements for Sec incorporation and allow for the application of genetic approaches in order to enhance or modify the specificity and processivity of the Sec incorporation reaction. In order to completely reconstitute efficient Sec incorporation in yeast and further modify the amino acid it specifies, we propose the following approach: Establish the Sec incorporation complex in the null system S. cerevisiae. We propose to express sub-sets of mammalian Sec incorporation components in the yeast S. cerevisiae utilizing novel constitutive promoters with exogenous tags in three phases. These phases systematically build the complete Sec machinery in vivo. By applying reporter systems directed at specific UGA codons we can demonstrate in vivo Sec incorporation. • Phase 1. Serylation of tRNASec in yeast. • Phase 2. Conversion of Ser-tRNASec to Sec-tRNASec in vivo. • Phase 3. Establish SECIS dependent Sec incorporation in vivo using reporter constructs. Apply a directed genetic approach to the enhancement and modification of the Sec incorporation system in vivo. • Demonstrate the ability to expand the Sec incorporation machinery identified by genetic methods in yeast. • Screen for enhancers of Sec incorporation utilizing a human cDNA library expressed in yeast. • Screen tRNASec and eEFSec mutants that promote specific stop codon suppression to allow for modification of the aminoacyl moiety of the tRNASec.